A deep longitudinal analysis of next generation influenza vaccines in older adults

PROJECT SUMMARY
The WHO estimates that annual epidemics of influenza result in 3-5 million cases of severe illness and 300,000-
500,000 deaths. 90% of influenza-related deaths occur in older adults despite widespread vaccination programs
with vaccines tailored for this high-risk group. The estimated effectiveness of the influenza vaccine in the U.S.
for the 2018-2019 influenza season overall was 47%, but only 12-13% in older adults. There is therefore an
urgent need to understand the mechanisms that are turned on/off in older adults that result in their limited
response rate to the most commonly used influenza vaccine, Fluzone® High-Dose. There is also a need to
understand whether and why next-generation influenza vaccines might be more efficacious. Immunosenescence
is known to be associated with declines in optimal B cell and T cell adaptive immunity, however, our overall
understanding of the mechanisms of immunosenescence is incomplete. The central goal of this proposal is to
understand the mechanisms that lead to a loss of response to influenza vaccine in older adults through
establishment of the 3FluAging cohort of healthy older adults who will be vaccinated with three different
influenza vaccines three years in a row. We hypothesize that aging impacts specific regulatory mechanisms of
humoral immunity to reduce vaccine effectiveness. In Aim 1, we will establish a cohort of 60 healthy older adults
(≥65yrs) who will sequentially receive three different annual influenza vaccines, with serial blood and microbiome
sample collection during three years of follow-up. Participants will undergo regular clinical assessments. In Aim
2, we will decipher the magnitude and immunodominance pattern of the humoral response to influenza virus in
healthy older individuals upon vaccination. For each vaccine, we will characterize antibody titer and quality and
will define responders and non-responders. In Aim 3, we will characterize the epigenome, transcriptome,
cytokine production, and cell proportions of blood leukocytes in vaccinated healthy older participants. We will
identify specific (epi)genomic and functional signatures, and their longevity, associated with vaccine response.
We will also sequence all participants to uncover the role of genetic variation on influenza vaccine responses. In
Aim 4, we will assess the function of T helper cells and antigen presenting cells, specifically dendritic cells, in
influenza vaccine responders and non-responders. By identifying responders and non-responders for each
vaccine and integrating these data with baseline immune status multi-omic signatures, we will determine which
immune features can predict vaccine responsiveness. We expect to identify humoral immunity pathways that are
altered in aging that can be used as the basis for designing novel approaches to boost efficacy of the most
commonly used, as well as emerging, influenza vaccines.

Public health relevance
PROJECT NARRATIVE The estimated effectiveness of the influenza vaccine in the U.S. for the 2018-2019 influenza season in older adults (≥65 years) was only 12-13%, demonstrating an urgent need to develop new approaches to improve influenza vaccine responsiveness in this high-risk population who constitute 90% of the 36,000+ annual U.S. influenza deaths. In this project, we will recruit and longitudinally follow a cohort of 60 older adults, who will receive 3 different influenza vaccines over 3 subsequent influenza seasons, including the most commonly used vaccine Fluzone® High-Dose and the first FDA-approved adjuvanted influenza vaccine, FLUAD®. By performing comprehensive profiling of their blood antibodies and immune cells over time, we will be able to associate specific age-related immune alterations with vaccine responder or non-responder status, thus allowing us to pinpoint biological pathways that can be targeted to enhance vaccine efficacy and that can also help us to progress towards developing a universal influenza vaccine.